Mutant p53 as actionable cancer-specific target

Project Summary
The vast majority of p53 mutations are missense mutations in the DNA-binding domain (termed ‘mutp53’) that
generate conformationally aberrant proteins with broadly abrogated functions. Importantly, in the previous grant
cycle we generated new mouse models that definitively proved that certain hotspot missense mutant p53
proteins not only lose their tumor suppressor function, but acquire broad oncogenic gain-of-function (GOF)
activities (‘mutp53GOF’). Our humanized p53R248Q knockin mice (termed ’Q’ mice) provided the long-sought
compelling phenotype of faster onset of all spontaneously arising tumor types and significantly shorter survival
compared to p53null littermates. Importantly, our finding translates to human cancers. In Li-Fraumeni patients
harboring p53 germline mutations, the Q allele dramatically accelerates tumor onset by 10.5 years and leads to
increased mortality compared to p53null-like Li-Fraumeni patients. Moreover, accumulating evidence from TCGA
data suggests that sporadic cancer patients harboring specific GOF alleles have higher death rates than patients
with p53 mutations that are functionally null. GOF contributes to malignant progression with increased
proliferation, invasion, metastasis, chemoresistance, stroma remodeling and reprogrammed metabolism. A
central feature of GOF is that mutp53 proteins exhibit massive constitutive stabilization, and that stabilization is
the prerequisite for exerting GOF. We identified the HSP90 chaperone machinery, which protects mutp53 from
its E3 ubiquitin ligases, as a major determinant of stabilization in vivo. Globally about 11 million people are living
with tumors expressing highly stabilized mutp53. Importantly, our findings indicate that the oncogenic wiring of
mutp53 tumors fundamentally differs from p53null tumors, which historically was the premier preclinical model
used. Notably, we established that autochthonous mutp53GOF cancers develop a strong dependency on
continued expression of high levels of mutp53 for tumor growth, maintenance and metastasis. Consequently,
acute genetic (via floxQ) or pharmacologic (via Hsp90 inhibitors) ablation of mutp53 triggers strong tumor
cytotoxicity in two distinct GOF mice, translating to major gains in survival by up to 59%, even in the absence of
wildtype p53. These paradigm-shifting results identify mutp53 as an actionable cancer-specific drug target. Aim
1 So far we demonstrated GOF resulting in mutp53 tumor dependency - and its therapeutic exploitability - in the
context of lymphoma and colorectal carcinoma. We will evaluate the therapeutic potential of targeting mutp53 in
other major tumor types, specifically in epithelial-derived models of liver and pancreatic carcinomas. Aim 2 will
determine the in vivo core network of pathways and interaction partners mediating mutp53GOF. We will use
ChIPseq/RNAseq and functional proteome analyses to directly observe the dynamic events that occur upon p53
mutation during transformation in primary mutp53GOF-driven lymphoma. Aim 3 will use genome-wide
transcriptional perturbation via CRISPR-mediated gene repression and activation to identify critical genetic
sensitizers as novel therapeutic targets specific for mutp53GOF cancer cells.

Public health relevance
Project Narrative In contrast to other tumor suppressors, the vast majority of p53 alterations in human cancers are very discrete mutations that incorporate a single faulty amino acid in the central DNA-binding part of the molecule and generate abnormally stabilized mutant proteins (called ‘mutp53’). Compelling evidence from mutp53 knockin mice as well as emerging evidence from human cancers indicate that many of these mutp53 alleles acquire new oncogenic gain-of-function (GOF) which actively contribute to tumor progression. Using genetic and pharmacological removal, we demonstrated that such tumors exhibit a strong dependency on continued expression of mutp53 for tumor growth, maintenance and metastasis. mutp53 depletion induces tumor cell death and leads to major survival gains in preclinical mouse models. Thus, mutp53 represents an exploitable cancer-specific drug target. The main goal of this project is to build on these findings and explore mutp53GOF in a broader cancer context, determine the core molecular mechanisms underlying GOF activity and identify novel druggable targets specific for mutp53 cancers.